Leveraging omics data to understand sleep health and its consequences among diverse Hispanics/Latinos

PROJECT SUMMARY
Hispanics/Latinos are the fastest growing demographic group in the U.S., expected to comprise 24% of the US
population by 2060. Latinos experience high rates of health disparities, including a high burden of
cardiovascular risk factors, diabetes mellitus (DM), uncontrolled hypertension (HTN), obesity, and Alzheimer’s
Disease and vascular dementias. The Hispanic Community Health Study/Study of Latinos (HCHS/SOL) is a
longitudinal cohort study established in 2004, following ~16,500 US Latinos from four geographic areas and
from multiple Latino backgrounds (Mexican, South American, Central American, Cuban, Dominican, and
Puerto Rican). We oversaw the collection and analysis of sleep measures during its baseline exam. Along with
our colleagues, we identified a high prevalence of sleep disorders which varied in frequency by social and
behavioral factors and Latino background, and associated with incident DM, HTN, and cognitive decline and
impairment.
In this project we will apply an integrative and multi-disciplinary research to study biological mechanisms that
result in sleep health-related risk of DM, HTN, and cognitive decline across diverse Latinos. First, we will
identify methylation and metabolomics measures associated with sleep phenotypes, and characterize them
biologically. We will link some of them to modifiable lifestyle and sociocultural measures. Second, we will
develop metabolomics and methylation biomarkers of sleep by combining information across multiple makers.
We will study the association such biomarkers with incident outcomes (DM, HTN, cognitive decline and
impairment). Third, we will estimate the effect of sleep phenotypes on modifying genetic risks for DM, HTN,
and cognitive outcomes using a gene-by-sleep interaction analysis with polygenic risk scores for each
outcome. We will also perform multi-omics analyses synthesizing multiple omics measures to understand
biological pathways. Finally, we will apply causal analysis to quantify the potential reduction in risks of incident
DM, HTN, and cognitive decline and impairment following potential intervention on sleep phenotypes, under
the assumption that metabolomics and genetic pathways can be blocked. We will estimate these effects in
aggregate and across Latino backgrounds. Our work will lead to development of public health interventions at
the community level (e.g., addressing strategies to improve sleep health) and at the personal level: by
identifying individuals who will benefit most from improving their sleep, for example, according to their genetics
or metabolomics profile.

Public health relevance
PROJECT NARRATIVE We will use a comprehensive dataset of diverse Latinos from the Hispanic Community Health Study/Study of Latinos to characterize biological mechanism underlying the relationship between sleep and incident cardiometabolic and neurocognitive outcomes. We will identify and construct metabolomics and methylation biomarkers of sleep phenotypes and study how these biomarkers associate with health and disease outcomes. We will study how sleep modifies effects of polygenic risk scores on outcomes and quantify the potential reduction in risk due to intervention on sleep and the resulting modification of omics pathways.